GYROSCOPE FOR USE IN PROSTHESES FOR STANDING AND WALKING

The long term objective of this research is to develop sensory systems for neural prostheses designed to restore useful movement in certain neurological disorder's. In this initial 6 month Phase 1 of the project we will focus on sit stand, standing and stand sit activities and evaluate a new sensory system based on our existing prototypes using available MEMS (micro electromechanical systems) rate gyroscopes and accelerometers. The specific aims are: 1) To develop a modular sensory system based on our existing prototypes in which miniature multi-axial rate gyroscopes and accelerometers are incorporated into small enclosures attached to the body. 2) Using able-bodied volunteers investigate the feasibility of computer algorithms to extract kinematic data for sit-> stand-> sit maneuvers. 3) Three mid-thoracic paraplegics who have used electrical stimulation to assist them to stand-up will be selected for FES standing tests. The hip and knee joint motion extracted from the new sensory system with those recorded using Penny and Giles goniometers. Sit->Stand and Stand->Sit motions will be statistically compared. PROPOSED COMMERCIAL APPLICATIONS: Applications are envisaged for the control of neural prostheses (surface or implanted electrodes), clinical gait analysis, ergonomics, virtual reality and sports training.